Breast cancer survivorship in the era of climate change: Impact of extreme weather, air pollution, and cancer therapy on heart and lung health

ABSTRACT
Climate change is a global public health emergency that will increase cardiovascular (CV) and
respiratory/pulmonary (R/P) morbidity and mortality as the population is exposed to more frequent extreme
temperature events and high levels of air pollution from wildfires. The synergistic effects of heat in the
presence of elevated air pollution increases mortality. CV and R/P morbidity and mortality are also health
consequences of certain breast cancer therapies that cause the heart and lungs to function at lower than
optimal levels. This therapy-related tissue damage may increase survivors' susceptibility to CV and R/P
disease from extreme temperature and air pollution. In this grant, we will identify breast cancer survivors'
unique health risks from climate change, by elucidating: · Exposure mechanisms/timeframes of interest,
including whether pre-diagnosis exposure climate-related conditions (temperature, wildfire smoke, air pollution)
during cancer therapy and post-diagnosis acute exposure to these conditions predispose breast cancer
survivors to greater CV and R/P toxicity; · How survivors' risks compare to individuals without cancer; and ·
Which breast cancer survivors face the greatest health risks from climate change, such as Hispanic women or
those with low socioeconomic status. To answer these questions, we will utilize a statewide Utah cohort of
21,835 female breast cancer survivors developed using the Utah Population Database, an epidemiologic data
resource that contains lifetime medical data and longitudinal residential histories. This resource enables us to
measure exposure to temperature and air pollution both prior to diagnosis and in the years following. We will
also utilize a cancer-free, age-matched female population sample (N=65,503). We aim to: 1) Determine if pre-
diagnosis, long-term exposure to extreme temperature and air pollution are associated with CV and R/P health
outcomes occurring while BC survivors are on therapy, limited to <5 years from diagnosis. 2) Estimate the
association of CV and R/P health outcomes and post-diagnosis, short-term exposure to extreme temperature
and air pollution from diagnosis onwards. 3) Identify differences in the effect of pre-diagnosis, long-term
exposure to extreme temperature and air pollution on the CV and R/P health outcomes between breast cancer
survivors and a cancer-free cohort. By identifying extreme temperature conditions and air pollution levels that
are specifically harmful to breast cancer survivors and whether high-risk survivor subgroups face greater risk,
this will allow the development of supportive care efforts to manage cancer-related health effects that are
exacerbated due to climate change.

Public health relevance
NARRATIVE Climate change will exacerbate cardiovascular (CV) and respiratory/pulmonary (R/P) morbidity through increasing extreme temperatures and periods of high levels of air pollution from wildfires. Certain cancer therapies can increase breast cancer survivors' propensity for CV and R/P disease, and may increase survivors' susceptibility to health problems from climate change. We will determine whether: 1) survivors exposed to extreme temperature and air pollution prior to diagnosis have a higher risk for therapy-related CV and R/P problems, and 2) if post-diagnosis short term exposure to extreme temperature and air pollution during treatment increases survivors' risk for CV and R/P problems related to climate change.